Improving cryoEM and cryoFIB performance through amelioration of mechanical stress in vitreous ice.

Project Summary/Abstract
Stress introduced during vitrification has been proposed as a likely cause of two
experimentally-observed methodological challenges: loss of resolution in cryo-electron
microscopy (cryoEM) and attrition of lamellae milled in cryo-focused ion beam
micromachining (cryoFIB). CryoEM is limited by a loss of information when the first
few electrons strike, and mounting evidence points to beam-catalyzed relaxation of the
built-up stress as the cause. A limitation of cryoFIB is that milled specimens break or
snap during milling because of stress, but the source of this stress has not been shown.
When specimens are prepared by plunge-freezing, water expands while the
specimen support contracts. Additives that disrupt the open hydrogen-bonding network
of water change its thermal expansivity. We will use volume-modulating excipients to
change the thermal expansion coefficient of cryoEM and cryoFIB samples and eliminate
mechanical stress from this source.
Rheological properties of ice suggest that thermal annealing of cryoEM grids will
allow solvent to flow and alleviate stress. We will warm cryoEM grids without
devitrifying them to relieve stress.
Therefore, our goal is to test whether volume-modulating excipients or
thermal annealing will solve the problem of beam-induced motion and
improve performance by 1. increasing resolution in cryoEM and 2. increasing
yield in cryoFIB.

Public health relevance
Project Narrative The “resolution revolution” in cryoEM transformed structural biology and continued increases in resolution and throughput improve its utility to drug design and basic biology. Improvements have come from almost all aspects of the technique except improving the ice itself. Coming from the perspective of nanomechanics, we will test two concepts to relieve this stress so that all structural biologists can obtain improved results.